Somatic Truncation Mutations of the Histone Methyltransferase MLL4 Alter Its Subcellular Localization in Bladder Cancer: Mechanistic Insight and Targeted Therapeutic Approach

PROJECT SUMMARY/ABSTRACT: KMT2D is subject to a high frequency of recurrent somatic mutations in
many cancers, most notably bladder cancer (BLCa), and nearly 40% of KMT2D mutations lead to truncation or
other major alteration of its product, the COMPASS monomethyltransferase MLL4. However, the tumorigenic
mechanisms specific to MLL4 truncation have yet to be fully elucidated. The preliminary and published studies
presented here reveal that truncated MLL4 consistently re-localizes from the nucleus to the cytosol, indicating
the potential for non-canonical tumorigenic mechanisms arising from MLL4 truncation mutations, which could
involve loss of catalytic-independent MLL4/COMPASS functions or a potential gain of function for truncated
MLL4 in the cytoplasm. Importantly, cytoplasmic MLL4 is readily detectable in bladder tumors with MLL4
truncation. The goal of this application is therefore to accomplish three specific Aims: 1. Define the molecular
mechanisms by which MLL4 truncation mutation and relocalization to the cytosol alter MLL4/COMPASS function
to drive tumorigenesis, 2. Develop MLL4 mutation status and cytoplasmic localization as predictive biomarkers
for patient stratification and targeted therapy in BLCa, and 3. Evaluate the impact of MLL4 mutation on response
to pemetrexed treatment using in vivo animal models and patient-derived ex vivo models of MLL4/COMPASS-
mutated BLCa. In Aim 1, we build upon preliminary findings of genomic instability due to transcriptional
dysregulation in SET-deleted and UTX KO cells to propose ChIP-seq analysis of differential chromatin
occupancy for nuclear MLL4/COMPASS factors such as UTX, with RNA-seq for associated differential gene
expression, in isogenic MLL4 truncation vs WT cell lines. Based on preliminary findings of interaction between
truncated MLL4 and the de novo nucleotide synthesis enzyme PAICS, we also propose to employ mass
spectrometric analysis of MLL4 purified from these isogenic lines to identify and characterize novel, cytoplasmic
protein interaction partners of truncated MLL4. These studies have the potential to deliver MLL4 truncation-
specific targets for small molecule disruption, enabling development of targeted cancer therapies. In Aim 2, we
propose to establish the association of cytoplasmic MLL4 IHC staining with MLL4 truncation mutation status in
BLCa patient samples and perform a retrospective study exploring the potential use of MLL4 mutation status in
BLCa for predicting responsiveness to the methotrexate-containing chemotherapy MVAC. These applied studies
have the potential to enable patient stratification and informed treatment decision-making, advancing progress
towards individualized BLCa treatment. In Aim 3, we build upon our recently reported finding of a targetable de
novo nucleotide synthesis dependence in MLL4-mutated cancers, proposing studies to evaluate BLCa sensitivity
to the de novo nucleotide synthesis inhibitor pemetrexed in vivo and to further evaluate MLL4 mutation-specific
responsiveness to pemetrexed in autochthonous mouse and patient-derived organoid models of BLCa. These
pre-clinical studies have the potential to support future clinical trials of targeted therapies for MLL4-mutated BLCa.

Public health relevance
PROJECT NARRATIVE: The important chromatin modifier MLL4 is frequently mutated in many cancers, with highest mutation frequency in bladder cancer (BLCa); nearly 40% of these mutations cause MLL4 protein truncation, which we have found results in a shift in the subcellular localization of MLL4 from the nucleus to the cytoplasm. In this application we propose biochemical studies that will fill a major gap in our understanding of how MLL4 truncation mutations drive tumorigenesis in general and in BLCa, applied studies that will develop MLL4 mutations and/or cytoplasmic MLL4 as biomarkers used in diagnosis and treatment decision-making for BLCa patients, and pre-clinical studies that will evaluate the effectiveness of pemetrexed for treating BLCa with MLL4 mutations. The proposed studies have the potential to enable development of novel targeted therapies for MLL4-mutated cancers, advance progress towards individualized BLCa treatment that would reduce patient burden, and support future clinical trials of targeted therapies for effective treatment of MLL4-mutated BLCa.